GROWTH HORMONE DEFICIENCY AND MUSCLE IN FIBROMYALGIA

The specific aim of the portion of the project is to determine the relationship between decreased muscle function and muscle bioenergetics, membrane abnormalities, and cross-sectional area in FM patients.